circRNAs as markers of life stress and experience during aging

PROJECT SUMMARY
Aging is a major risk factor for numerous diseases and is modulated by both genetic and environmental
factors. However, dissecting the interplay between environmental stressors and aging remains challenging.
This is partly because traditional stress markers are transient, complicating the retrospective analysis of
environmental stimuli and their contribution to the aging process. Consequently, there is a critical need for
novel, stable markers that can track both the aging trajectory and the life stress history of an organism,
including exposure to toxins and underlying health conditions. Such markers could significantly enhance our
ability to predict the propensity to develop age-related disorders.
Circular RNAs (circRNAs) are a highly stable and abundant class of RNA generated by circularization of
specific exons. Their stability allows them to accumulate with age, particularly in non-dividing cells such as
neurons. Indeed, our findings indicate that circRNAs exhibit very long half-lives (exceeding 20 days) in the
Drosophila brain, with some showing no degradation over the animal’s lifetime. Moreover, we found that
circRNAs can accurately track age, and that their levels are influenced by environmental stimuli such as
oxidative stress, temperature, light exposure, and starvation. This combination of exceptional stability,
capability to function as age markers, and induction by environmental stimuli implies that circRNAs can
serve as life experience markers. Indeed, flies subjected to a ten-day regimen at 29°C exhibit higher levels
of specific circRNAs even six weeks after returning to standard conditions, indicating that circRNAs can reveal
past exposure to environmental stimuli. This positions circRNAs as unique molecules capable of
integrating aging and stress information which could help uncover early-stage stages of disease or organ
malfunction and determine if animals have been exposed to dangerous substances in the past. Additionally,
these results suggests that circRNAs induced upon exposure to stimuli could be relevant for the responses
upon re-exposure to the stressor. In this project, we aim to establish circRNAs as robust markers for tracking
the integrated transcriptome and stress history of populations during aging. In this context, we plan to:
1) Identify circRNA subsets for tracking chronological age, aging and environmental stress exposure.
and 2) Determine the encoding capacity of circRNAs as life experience and aging markers. By refining
circRNA signatures to accurately reveal the stress history of Drosophila populations and their relationship to
aging, we aim to develop new predictive markers for age-related diseases. This project is particularly relevant
in the context of an aging human population and in the search of new markers that could predict the
presence and predisposition to age-related diseases.

Public health relevance
PROJECT NARRATIVE The goal of the proposed project is to determine whether circular RNAs (circRNAs) can serve as novel biomarkers for assessing exposure to past stressors and their impact on aging. This research is particularly relevant in the context of an aging human population and in the search of new markers that could predict the presence and predisposition to age-related diseases.